Stem Cell and Cancer Biology Program

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
STEM CELL AND CANCER BIOLOGY PROGRAM - PROJECT SUMMARY/ABSTRACT
The overarching goal of the Stem Cell and Cancer Biology (SCCB) Program is to provide fundamental insights
into the basic cell and molecular mechanisms facilitating cancer evolution, progression and therapy resistance
which enable the identification of novel anti-cancer strategies. To achieve this mission, the Program has three
specific aims, which are to: (1) discover mechanisms underlying the evolution of malignant cancer (stem) cells;
(2) delineate drivers of cancer progression and therapy resistance; and (3) characterize the principal
mechanisms establishing and governing cellular differentiation and identity. The strategy for successfully
carrying out this mission requires the involvement of basic, preclinical, and clinical/translational research. The
SCCB Program critically relies on a diverse and broad spectrum of scientific expertise encompassing highly
focused molecular and cell physiological mechanisms, and is substantiated through various model organisms
and platforms. It also relies upon collaborations with other MECC research programs, including the Cancer
Therapeutics Program for clinical translation of new discoveries by SCCB members that have translational
applications. Centralized MECC support, particularly Shared Resources, such as (but not limited to) the Animal
Model Shared Resource, Biostatistics Shared Resource, Genomics Shared Resource, Analytical Imaging
Facility, Flow Cytometry Shared Resource, and Cancer Biorepository Shared Resource, greatly facilitates,
streamlines, and enhances SCCB research.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward STEM CELL AND CANCER BIOLOGY PROGRAM - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page